Growth Hormone, Mitochondria, and Cardio-metabolic Complications of Obesity

DESCRIPTION (provided by applicant): Abdominal obesity is associated with significant morbidity, including hypertension, dyslipidemia, insulin resistance and increased cardiovascular disease risk. Growth hormone (GH), a pituitary gland derived anabolic hormone which stimulates lipolysis, is reduced in association with excess abdominal obesity. The reduced GH associated with obesity can be normalized with weight loss, suggesting a relative or functional deficiency. Relative GH deficiency of obesity is associated with increased cardio-metabolic risk independent of traditional cardiovascular risk factors. Furthermore, treatment of obese subjects with GH results in loss of visceral adiposity and improvement in cardio-metabolic risk markers, suggesting a causal association between relative GH deficiency and obesity-associated cardio-metabolic risk. As GH stimulates lipolysis, and lipolysis/2- oxidation is primarily a function of mitochondria, the potent effect of GH to oxidize fat suggests potential effects of GH on mitochondrial function. However, the relationship between GH and mitochondrial function has yet to be clarified in humans, and it is not yet known if GH affects skeletal muscle mitochondrial number, morphology or function. We hypothesize that reduced GH secretion associated with obesity contributes to defects in mitochondrial function which can be improved by normalizing endogenous GH. To evaluate the relationship between reduced GH associated with obesity and mitochondrial dysfunction, the candidate will be mentored by internationally recognized experts in clinical metabolic/physiology research, assessment of in vivo mitochondrial function, and molecular biology and microscopy techniques. The K23 award will support both formal and informal training designed specifically to provide the necessary skills in translational human research which will include training in clinical research methods specific to evaluation of obesity, GH, metabolism, mitochondrial biology and cardiovascular disease risk assessment, biostatistics, and ethics of human research through the Harvard School of Public Health, Massachusetts General Hospital, and scientific workshops, symposia and meetings. Daily interactions with the candidates' mentors and colleagues will further enhance his training and career development. The combination of the candidates' prior back ground in basic science research and his growing expertise in clinical investigation places him in a unique position to develop a translational research career which will both deepen our understanding of obesity and result in development of novel therapies for obesity and its associated complications.

Public health relevance
PUBLIC HEALTH RELEVANCE: Metabolic and cardiovascular complications of obesity have increased in parallel with the obesity epidemic in recent years. However, non-surgical treatments for obesity are only minimally efficacious and options remain sparse. Given the known role of growth hormone in stimulating lipolysis and the recognized role of mitochondria in mediating 2-oxidation, manipulations of the growth hormone axis to target mitochondrial function is an intriguing prospect for the treatment of obesity and its co-morbidities. 8. Project Narrative Metabolic and cardiovascular complications of obesity have increased in parallel with the obesity epidemic in recent years. However, non-surgical treatments for obesity are only minimally efficacious and options remain sparse. Given the known role of growth hormone in stimulating lipolysis and the recognized role of mitochondria in mediating β-oxidation, manipulations of the growth hormone axis to target mitochondrial function is an intriguing prospect for the treatment of obesity and its co-morbidities. __SpecificAimsTextDelimiter__ SPECIFIC AIMS: Obesity is associated with significant co-morbidities including hypertension, dyslipidemia, insulin resistance and increased cardiovascular disease (CVD) risk. Although both abdominal visceral adipose tissue (VAT) and abdominal subcutaneous adipose tissue (SAT) are increased in obesity, VAT is more closely associated with increased cardio-metabolic risk. Growth hormone (GH), a pituitary gland derived anabolic hormone which stimulates lipolysis, is reduced in association with excess VAT and contributes independently to increased CVD risk in obesity. Furthermore, treatment of abdominally obese subjects with GH results in a specific decrease in VAT and improvement in cardio-metabolic risk markers. As β-oxidation occurs in the mitochondria, the potent effect of GH to oxidize fat suggests potential effects of GH on mitochondrial function. However, the relationship between GH and mitochondrial function has yet to be determined in humans, and it is not yet known if GH affects mitochondrial number, morphology or function. The hypothesis of this grant proposal is that GH effects skeletal muscle mitochondrial number, size and function. We hypothesize that reduced GH secretion in obesity contributes to defects in skeletal muscle mitochondrial physiology which can be improved by normalizing endogenous GH. This novel hypothesis will be tested in the current grant proposal, which affords a unique opportunity for mentored training in clinical and translational research while filling a gap in the field and potentially leading to a treatment for obesity. Aim I: We will investigate the association between GH secretion and mitochondrial function in vivo, using 31Phosphorous-magnetic resonance spectroscopy (MRS), and ex vivo, using cellular and molecular biology techniques from muscle biopsies in a prospective, observational study among normal weight and obese subjects. We will evaluate mitochondrial size, number, morphology and sub-cellular localization using traditional microscopy techniques and we will evaluate expression levels of genes involved in mitochondrial biogenesis and function through real-time PCR from tissue obtained by skeletal muscle biopsies. In addition, we will evaluate CVD and metabolic risk by measuring carotid intima-media thickness (IMT), performing oral glucose tolerance test, and measuring cholesterol profile and inflammatory markers. The relationship between GH status, mitochondrial function, morphology, expression of mitochondrial genes, and CVD and metabolic risk will be examined. We hypothesize that reduced GH secretion in obesity is associated with mitochondrial dysfunction which may contribute to increased cardio-metabolic risk. We hypothesize that: 1. Obese GH deficient subjects will have significant skeletal muscle mitochondrial dysfunction compared to lean and obese subjects with GH sufficiency. 2. Mitochondrial dysfunction will be associated with altered mitochondrial morphology, decreased mitochondrial size and number as well as decreased mRNA expression levels of genes involved in mitochondrial biogenesis and function among obese subjects with reduced GH. 3. Mitochondrial dysfunction will be associated with a greater degree of insulin resistance, inflammation, dyslipidemia and increased carotid IMT among obese subjects with reduced GH. Aim II: We will conduct a 12-month, double-blind, randomized, placebo-controlled trial of TH9507, a novel growth hormone releasing hormone1-44 (GHRH) analog, to augment endogenous physiological GH secretion and pulsatility in obese patients with reduced GH levels. We will assess the impact of this strategy on in vivo skeletal muscle mitochondrial function, ex vivo skeletal muscle mitochondrial morphology and expression of mitochondrial genes at 0, 6 and 12-months. We hypothesize that: 1. In vivo mitochondrial function will improve after treatment with TH9507, a strategy designed to improve altered GH pulse dynamics in obese patients with reduced GH. 2. Improvement in mitochondrial function will occur in association with an increase in mitochondrial size and number as well as in the expression levels of genes involved in mitochondrial biogenesis and function in obese patients with reduced GH after treatment with TH9507. 3. Improvement in mitochondrial function will occur in association with improvement in VAT, insulin sensitivity, cardiovascular risk factors, inflammatory cytokines and carotid IMT in obese patients with reduced GH after treatment with TH9507.